Novel mechanisms of epigenetic regulation in stress and depression: toward a precision medicine model

PROJECT SUMMARY/ABSTRACT
Depression is a leading cause of illness and disability worldwide, with a two-fold higher incidence in women than men. Stress is a well-established risk factor for depression. Studies to date showed that stress leads to epigenetic reprogramming of gene expression key for neuronal plasticity of brain circuits such as the ventral hippocampus, which has been implicated in depression. We previously reported that: 1) administration of acetyl-L-carnitine (LAC), leads to a rapid and persistent antidepressant-like response by increasing a chronic stress-induced suppression of H3K27ac and the related expression of a key inhibitor of glutamate release mGlu2 receptor in vDG glutamatergic neurons; and 2) LAC levels are decreased in subjects suffering from depression. The objective of this application is to understand the role of LAC-related mitochondrial metabolism in the regulation of stress responses. This contribution will advance our understanding of cellular and molecular mechanisms of mitochondrial metabolism for stress responses, and identify sex-differences in these mechanisms.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the public because stress is a well-established risk factor for main psychiatric diseases, including depression. Motivated by our recent findings of decreased levels of acetyl-L-carnitine (LAC) in clinical depression, we seek to understand the role of mitochondrial metabolism of LAC in the regulation of stress responses. This work will lead to development of new models of resilience to stress, ultimately decreasing the burden of depression among other stress-related disorders.